Characterizing the Genetic Risk for Alzheimer Disease in African and Admixed African-American Ancestries

ABSTRACT
AD is the leading cause of dementia in the elderly in all ethnic and racial groups, but most genetic studies for AD
are in non-Hispanic Whites (NHW) of European ancestry, resulting in a lack of generalizability of findings across
more diverse ancestries. This is problematic, as initial studies in African Americans (AA), who have a higher
prevalence of AD compared to NHW, have already revealed differences in risk effect sizes in known loci (e.g.,
APOE; ABCA7), indicating multiple unique patterns of risk. Therefore, the Alzheimer's Disease Sequencing
Project (ADSP) aims to encompass the richest possible ethnic diversity and currently includes over 55,000
funded samples for whole genome sequencing (> 19,000 NHW, >14,000 HL ancestry, and > 8,000 African
Ancestry cases and controls). Thus, in this ADSP-FUS 2.0 application, which focuses on the PAR-21-212 goal
to increase diversity cohorts in the ADSP, we are proposing generating whole genome sequencing, AD plasma
biomarkers and cardiovascular disease biomarkers in an additional ~9,000 individuals of African ancestry
(~5,000 African, ~4,000 African American) ascertained as part of the ongoing “Recruitment and Retention for
Alzheimer's Disease Diversity Genetic Cohorts in the ADSP” (READD-ADSP U19 AG074865). Further, we will
acquire MRI data from 200 Nigerian participants. We will perform longitudinal follow-up visits on mild cognitively
impaired and cognitively unimpaired individuals after ~4 years to further evaluate clinical and biomarker level
changes longitudinally associated with status conversion. This increase in sample size enhances our ability in
this proposal to detect and analyze rare genetic variants contributing to the risk and protection of AD in individuals
of African ancestry and understand underlying risk correlated with cardiovascular disease risk and AD plasma
biomarkers. Taken together, this project will leverage the resources collected under the READD-ADSP to begin
to unravel the AD risk for individuals of African ancestry while providing an invaluable resource for the AD
research community at-large.

Public health relevance
PROJECT NARRATIVE This project will provide whole genome sequencing (8,100), Alzheimer's disease (AD) plasma biomarkers (7,500), and cardiovascular disease (CVD) risk biomarker data (9,000) on African and African American individuals ascertained as part of the READD-ADSP U19. We will also collect longitudinal clinical and plasma biomarker data by recontacting and performing follow-up visits after ~4 years with cognitively intact and mild cognitively impaired individuals from this cohort. Analysis of this data will allow identification of rare genetic variants contributing to AD risk and protection and include biomarker and CVD markers in these models. This will add to this invaluable resource for the Alzheimer's disease (AD) research community to enhance efforts to discover targets for AD diagnosis, prevention, and treatment that apply to individuals of all ancestral backgrounds.